Enriching Undergraduate Research Experiences & Knowledge Applied in Environmental Health Sciences (EUREKA-EHS)

PROJECT SUMMARY/ABSTRACT:
Among the various minority groups, American Indian and Alaskan Native (AI/AN) people continue to be
significantly under-represented in many STEM and biomedical-based fields, including Environmental Health
Sciences (EHS). The Department of Life Sciences at Salish Kootenai College (SKC), a well-established and
vibrant tribal college on the Flathead Indian Reservation in Montana, was previously awarded a research
education program grant to associate indigenous and rural students to the field of EHS through the creation of
the only 4-year EHS program at a tribal college in the US. The current competitive renewal “Enriching
Undergraduate Research Experiences & Knowledge Applied in Environmental Health Sciences (EUREKA-
EHS)” proposes to leverage these previous successes to further support the development of undergraduates for
employment and entry into advanced degrees in EHS. The goal of the proposal is to continue using established
High-Impact Practices in education and research that have proven to engage and retain tribal students while
minimizing the gap between indigenous- and western-ways of thinking in science. Likewise, the proposal seeks
to draw on the unique tribal educational ecosystem and a nurturing model to mentor 15-20 internal and external
research participants over five years. To accomplish these goals, EUREKA-EHS aims to specifically: 1) EXPAND
research that emphasizes more EHS- and place-based student experiences, utilizes Traditional Ecological
Knowledge & Wisdom (TEKW) in tribally-relevant projects through an interdepartmental collaboration, and
invited EHS and/or indigenous speakers to compliment these research efforts; 2) ENHANCE education with a
co-taught Ethnopharmacology course from a dual knowledge perspective, explore indigenous identity and foster
interactions with role models using a regional health professional network or SKC-affiliated EHS Navigators, and
promote indigenous leadership and wellness capacity. Based on the previous outcomes, successful completion
of the renewal will allow for enriched educational activities and quality research opportunities that are critical for
creating a pool of talented scientists with a dual knowledge perspective in EHS.

Public health relevance
PROJECT NARRATIVE: The current renewal seeks to strengthen the recently created Environmental Health Sciences (EHS) ecosystem at Salish Kootenai College (SKC), a tribal college that serves multiple indigenous communities. The program aims to development more focused, place-based projects that are relevant to diverse tribal communities. The program also aspires to promotes educational and leadership building opportunities to better prepare undergraduates for successful advancement to advanced degrees and employment in EHS-related fields.